Structure and Mechanism of Eukaryotic Transcription Regulation

Summary
Transcription is the first step to read out the genetic information stored in the chromosome. In eukaryotes,
three multi-subunit RNA polymerases (Pols), Pol I, II, and III transcribe the 25S ribosomal RNA (rRNA),
protein-coding, and short non-coding RNAs such as transfer RNA (tRNA) and 25S rRNA genes, respectively. A
wealth of genetic and biochemical data accumulated over 50 years have uncovered most of the molecular
players involved and details of the intricate regulatory circuits. The recruitment and assembly of the initiation
complex at the promoter represent one of the key regulatory steps during gene expression. The Pol II initiation
machinery includes the activator-bound Mediator along with a series of general transcription factors (GTFs)
(TFIID, TFIIA, TFIIB, TFIIE, TFIIF, and TFIIH) that assemble into a ~4-megadalton (MDa) pre-initiation
complex (PIC) on core promoter DNA. On the other hand, the Pol III enzyme is recruited onto its promoter with
the help of corresponding GTFs (TFIIIC, TBP, BRF1, and B''). This proposal aims to investigate the
mechanism of transcription regulation by directly visualizing these transcriptional competent initiation
complexes using single-particle cryo-EM. Comparable pictures of these different but evolutionarily related
systems at this critical step of gene regulation will provide an unprecedented, comprehensive view of this key
process in the central dogma of molecular biology.

Public health relevance
Project Narrative Transcriptional regulation represents a major control mechanism of gene expression in eukaryotes. Cell-specific expression of ~20,000 genes in human cells requires hundreds of protein factors acting in a multistep manner. Through structural and functional studies, we seek to define the complex molecular mechanisms of gene transcription derived by different RNA polymerases at distinct regulatory steps.